Adapting and Testing a Smoking Cessation Intervention in Adults with Intellectual and Developmental Disabilities

ABSTRACT
Cigarette smoking is the leading cause of preventable death in the United States. Despite a substantial decrease
in cigarette smoking over the past decade, cigarette smoking accounts for nearly half a million deaths nationally,
more than alcohol and illicit drug use combined. People living with intellectual and developmental disabilities
(IDDs) are exceptionally vulnerable to dangers posed by cigarette smoking because it may worsen health
conditions common among people with IDDs, including diabetes and asthma. People living with IDDs are at an
increased risk of developing a tobacco use disorder (TUD), have a lower likelihood of entering treatment and
have a higher probability of dropping out of treatment. These issues highlight serious health equity concerns for
people with IDDs, including stigma, exclusion, underrepresentation, and lack of access to high quality care, and
may contribute to both the onset of cigarette smoking and serve as barriers to tobacco treatment enrollment,
thus making people with IDDs vulnerable to persistent TUD and tobacco-related disease. The goal of this
K99/R00 Pathway to Independence Award is to use a community engaged approach to elucidate treatment
difficulties in IDD populations and use the information gained from the community to adapt and test an evidence-
based smoking cessation intervention. Achieving this goal is a crucial step in a larger process of establishing an
essential line of research treating TUDs with people with IDDs. Through this K99 we aim to complete 40 semi-
structed interviews with staff and patients actively engaged and not engaged in tobacco treatment to 1) identify
barriers that contribute to low TUD treatment enrollment and high drop-out rates for people with IDDs, and 2)
select and adapt an existing intervention for use with those with IDDs. Through the R00 we will utilize the results
of our K99 to evaluate the feasibility, acceptability, and initial efficacy of a tailored, behavioral smoking cessation
intervention in this population. The modified intervention, based on findings from the K99, will be implemented
in a feasibility trial in people with IDDs. Outcomes will include intervention feasibility and acceptability (primary
outcome), self-reported cigarette smoking (secondary outcome) and cigarette smoking measured by expired
breath carbon monoxide (secondary outcome). The results of this project will inform the development and
implementation of a larger randomized controlled trial to be conducted as part of a future R01 grant. This project
will fill a profound research gap by understanding significant smoking treatment barriers and developing and
piloting a tailored smoking cessation intervention for people with IDDs. This award will include substantial training
and mentorship from a diverse group of K99 mentors who will supplement Dr. Regnier’s experience in the
application of evidence-based treatments to IDD populations, and provide him with skills in implementation
science, clinical trial research, community engagement and professional development that will help him obtain
his goal of becoming a leader in addiction research in people with IDDs.

Public health relevance
PROJECT NARRATIVE This project will increase our understanding of critical cigarette smoking treatment barriers for people living with intellectual and developmental disabilities. This project will also bridge a significant treatment-focused research gap between people with intellectual disabilities and the general population. The studies proposed in this K99/R00 will identify and adapt a tailored evidence-based smoking cessation treatment for people with intellectual and developmental disabilities (IDDs) utilizing stakeholder feedback and perspectives.